RHEOTHRX MULTIPLE DOSE SAFETY IN SICKLE CELL DISEASE PATIENTS NOT IN CRISIS

The purpose of this study is to assess the safety, pharmacokinetics and pharmacodynamics of Rheothrx in sickle cell disease.